Project 3 - INSM1, A Candidate Therapeutic Target in High-Grade Neuroendocrine Carcinomas

Project Summary/Abstract (Project 3)
Small cell lung cancer (SCLC), Merkel cell carcinoma (MCC), and neuroendocrine prostate cancer (NEPC) are
aggressive high-grade neuroendocrine carcinomas (HGNCs) with no approved targeted therapies. These
HGNCs highly express lineage-specific neuroendocrine transcription factors (NETFs) that promote
neuroendocrine differentiation and sustain their survival presenting a potential opportunity to target NETFs in
HGNCs. INSM1 is a C2H2-type zinc-finger transcriptional repressor that normally functions to control endocrine
differentiation during islet cell development of the pancreas. In contrast to the other NETFs which are only
expressed in subsets of HGNCs, INSM1 is more universally expressed across HGNCs and is commonly used
as a clinical biomarker for the pathological diagnosis of HGNCs. INSM1 is also unique in that it is a C2H2-type
zinc-finger transcription factor that shares homology with the druggable IKZF C2H2-type zinc-finger transcription
factor family that can be targeted by immunomodulatory (iMiDs) drugs such as lenalidomide. Our preliminary
data suggests that INSM1 is critical for survival and neuroendocrine differentiation in these three HGNCs. We
hypothesize that INSM1 is a therapeutic target for HGNCs and is druggable with iMiD small molecules. To test
this hypothesis, we will investigate the mechanistic role of INSM1 in controlling neuroendocrine differentiation
and survival in HGNCs using both genetic and pharmacological approaches in a variety of pre-clinical models of
SCLC, NEPC and MCC (Aim 1). We will utilize xenograft and patient-derived xenograft models to determine if
INSM1 is required for tumor maintenance in HGNCs (Aim 2). We have identified mechanisms by which HGNCs
normally degrade INSM1 protein and we will further investigate these mechanisms in the first part of aim 3.
Moreover, we performed an iMiD-derivative small molecule library screen and identified 3 lead iMiD compounds
that degrade INSM1. We will further test whether these iMiDs directly bind and degrade INSM1 and their
selectivity for INSM1 in the second part of aim 3. This project is built upon compelling preclinical data by the
project leaders in all three HGNCs and leverages their distinct expertise and unique preclinical models of
HGNCs. Successful completion of this project will lead to an enhanced mechanistic understanding of how INSM1
controls the neuroendocrine phenotype and proliferation of HGNCs, determine whether INSM1 inhibition by
targeted protein degradation has therapeutic efficacy in HGNC, and will identify small molecule iMiDs that can
bind and degrade INSM1 as a novel therapeutic strategy for HGNCs.

Public health relevance
Project Narrative (Project 3) INSM1 is a neuroendocrine transcription factor that is highly expressed in high grade neuroendocrine carcinomas (HGNCs), including small cell lung cancer, Merkel cell carcinoma, and neuroendocrine prostate cancer, and acts to promote neuroendocrine differentiation and survival. INSM1 is unique in that it shares homology with the druggable IKZF C2H2-type zinc-finger transcription factor family. Here we will dissect the function of INSM1 in three distinct HGNCs, determine whether INSM1 is required for tumor maintenance, and identify mechanisms and small molecules to degrade INSM1 as a novel therapeutic strategy to target INSM1 in HGNCs.